Mechanisms of sex selective enhancement of threat anticipation following early life adversity

PROJECT SUMMARY. Experiencing early life adversity (ELA), such as resource scarcity, is associated with
anxiety-related disorders, including generalized anxiety disorder (GAD). Women have a two-fold greater
prevalence of anxiety disorders, more robust presentation of symptoms, and poorer response to treatments. A
debilitating and core feature of GAD is heightened anticipation of threat when it is not necessarily present.
While responding to threat is adaptive, excessive anticipation in the absence of real threat can manifest as
pathology. Examining the neural correlates underlying threat anticipation is critical to understanding sex-
specific risk and developing effective treatments. ELA alters threat response circuitry, associated with
excessive recruitment of the central amygdala (CeA), a region important for threat learning. A neuropeptide,
corticotropin releasing hormone (Crh), within the CeA responds to threat-predictive cues and send long-range
projections to the bed nucleus of the stria terminalis (BNST), a region known for behavioral modulation in
response to stress. However, the impact of ELA on the Crh+ CeA to BNST projection and how sex-differences
within this projection may alter threat anticipation remains unclear. Thus, examining the Crh CeA to BNST
projection as a potential neurobiological target by which ELA enhances responses to threat will be central to
understanding neural underpinnings of pathology and sex differences in risk.
The startle response is an especially suitable endophenotype to study threat responding because it is
reliably enhanced when threat is explicitly cued. It also provides a useful translational tool, as the behavior has
been widely used in clinical settings. In preliminary studies, I used the limited bedding mouse model of ELA to
test its effects on startle response as an index of threat anticipation. I found that mice who experience ELA exhibit
enhanced startle to a loud noise both in the presence and absence of the conditioned tone, suggesting both
heightened and maladaptive anticipation of threat. Importantly, this effect was exclusive to females. I
hypothesize that anticipation of threat is driven by activation of CeACrh to BNST neurons and that ELA
female mice show excessive activation of this circuit both when threat is present and absent. In Aim 1, I
will test for sex- and ELA-specific differences of Crh CeA to BNST activity when threat is either present or absent
by using fiber photometry to visualize calcium activity from a population of CeA Crh neurons projecting to BNST
during the fear-potentiated startle task. In Aim 2, I will test the necessity of the CeA Crh to BNST projection for
anticipated threat by optogenetically inhibiting Crh BNST terminals from CeA in the presence of threat.
Ultimately, this knowledge may contribute to the development of proper treatments for anxiety disorders
that are individualized to the experience and sex of the individual. The training I will gain through this F31 award
will support my path towards becoming a well-rounded and independent research scientist focused on studying
animal models of pathology and the consequences of ELA on emotional development.

Public health relevance
PROJECT NARRATIVE Experiencing early life adversity (ELA), such as resource scarcity, increases the lifetime incidence of developing anxiety disorders, with women showing 2-fold greater risk. A defining feature of anxiety disorders is enhanced anticipation of threat, but the mechanisms driving anticipatory threat, how they are altered as a consequence of ELA, and how they support sex-differences in risk remains unclear. My proposal employs a translational behavioral assay in mice and advanced in vivo techniques to investigate the neural underpinnings of maladaptive threat anticipation and has enormous clinical relevance; the results will lay the groundwork for the development of more refined treatments for anxiety disorders that are tailored to the experience and sex of the individual.